PAP SMEAR QUALITY CONTROL USING OPTICAL CORRELATORS

DESCRIPTION: This project will develop a high speed optoelectronic hardware system for preprocessing Pap smears for "regions of interest" (R01's) and then analyze results of the system further, by using image analysis software. The latter will perform cytological classification in the regions of interest. The integrated system is targeted toward the screening of slides initially classified as negative, with a primary application in quality control.